Stakeholder Engagement Core

The overarching goal of the Stakeholder Engagement Core (SEC) is to ensure that technology solutions and
artificial intelligence approaches proposed and developed by the PennAITech Collaboratory are maximally
adoptable by and accessible to their end users by soliciting ongoing stakeholder input and involving all key
parties throughout all phases of the development and testing processes. Stakeholders include, but are not
limited to, older adults with and without Alzheimer’s disease and related dementias, family and other informal
caregivers, physicians, nurses and other clinicians involved in the care of older adults, administrators, policy
makers and technology partners. The aims of this core are to 1) establish, maintain and grow a technology
consortium (consisting of technology companies, startups, venture capital firms, and angel investors) that will
provide guidance and collaboration opportunities for pilot projects and a platform for potential dissemination
and commercialization of innovative tools; 2) engage older adults with and without Alzheimer’s disease and
related dementias, family and community members especially in rural and underserved areas in all activities of
the PennAITech Collaboratory; 3) engage clinicians and allied health professionals involved in the care of older
adults in activities of the PennAITech Collaboratory; and 4) engage policy makers and the public in knowledge
translation and dissemination activities.

Public health relevance
The PennAITech Collaboratory supports the development, evaluation, and implementation of artificial intelligence software and new technologies to facilitate healthy aging in the home. The goal of the Stakeholder Engagement Core is to ensure that technology solutions and artificial intelligence approaches proposed and developed by the PennAITech Collaboratory are maximally adoptable by and accessible to their end users by soliciting ongoing stakeholder input and involving all key parties throughout all phases of the development and testing processes.